Core A: Admin Core

Core A. Administrative and Research Support Core
PROJECT SUMMARY/ABSTRACT
The Administrative and Research Support Core (A) will provide direction and support for all activities of the
Duke Center for Population Health and Aging (CPHA), which, along with the Duke Population Research Center
(DPRC), anchor the Duke University Population Research Institute (DUPRI), which itself is organizationally
located within the Social Science Research Institute (SSRI) at Duke. The Center is led by a Director and an
Executive Committee with the support of an Advisory Committee. The primary goal of the Administrative Core
is to support the activities of CPHA and coordinate collaboration among CPHA scholars and affiliates (together,
“associates”). Core A will provide general administrative support and technical and research resources to
meet proposed objectives across all cores, with backup support from SSRI staff, facilities, and services. Core
A is designed to give CPHA associates the breadth and depth of administrative and research support required
to motivate and sustain innovative research and dissemination activities produced by cores B, C, and D. To
that end, CPHA shares three full-time staff members with DPRC within DUPRI, including a Director of
Administration and Research Development, a Director of Computational Resources, and a Program
Coordinator. These staff members assist the PI and center associates in achieving the aims of the center,
including collection and preparation of materials for disseminating research findings and activities to the
scientific and other communities including the public, as well as for meeting internal and external reporting
requirements (i.e., to SSRI, Duke, the Association of Population Centers, the P30 Coordinating Center, and
NIA). Because the staff are shared across the constituent centers that form DUPRI, they coordinate
administrative functions between centers, yielding an economy of scale that frees up resources within each
constituent center for greater training and mentoring opportunities and research innovation than could be
provided by a single center.